Analysis of Developmental Arrest and Treatment Resistance in High-risk T-ALL

Project Summary
Acute lymphoblastic leukemia (ALL) is the most common pediatric cancer, accounting for nearly 1 in 3 new
pediatric cancer diagnoses. Though mortality and morbidity associated with common ALL subtypes have
drastically improved as a result of advances in chemotherapy and risk stratification, high rates of treatment failure
persist in understudied subtypes of ALL, such as early T-cell precursor acute lymphoblastic leukemia (ETP-ALL).
ETP-ALL patients fail the first month of chemotherapy at 7.7x the rate of non-ETP ALL patients and are twice as
likely to have detectable residual disease at end of induction chemotherapy. We hypothesize that these striking
differences in response to treatment are intrinsically rooted in biological characteristics of ETP-ALL, which can
be further revealed using high-throughput measurement tools, such as single-cell genomics.
The completion of COG’s AALL00344 clinical trial, which enrolled 325 ETP-ALL patients, represents an exciting
opportunity to improve our understanding of ETP-ALL and identify the biological reasons for treatment failure. In
Aim 1, we will use single cell transcriptomics and single cell chromatin accessibility to investigate clonal diversity,
transcriptomic features and epigenetic signatures in 30 patients with ETP-ALL. We will seek to place ETP-ALL
blasts in context of healthy T-cell development and other pediatric leukemias. In Aim 2, we will compare ETP-
ALL patients based on clinical response and use patient-specific xenograph models to functionally perturb genes
and pathways enriched in non-responding patients. Our project is poised to synergize with bulk sequencing data
being generated for 325 ETP-ALL patients through an NIH X01 grant (HD100702-01), specifically due to our
ability to deconvolute bulk sequencing data using subclone-specific signatures discovered in single cell data.
We believe the proposed work can help to elucidate the genetic drivers of ETP-ALL and identify targets and cell
populations associated with treatment failure, thus significantly impacting the diagnosis and treatment of ETP-
ALL.

Public health relevance
Project Narrative New therapeutic strategies are badly needed in Early T-cell precursor Acute Lymphoblastic Leukemia (ETP- ALL), yet current biological understanding of this subtype of pediatric leukemia is limited. The completion of COG’s AALL00344 clinical trial, which enrolled 325 ETP-ALL patients, represents an exciting opportunity to improve our understanding of the biological reasons for treatment failure. Using single cell multi-omics coupled with patient-specific and large-scale computational validation studies, we will define molecular features of ETP- ALL that explain treatment resistance, improve understanding of carcinogenesis and its relation to normal T-cell development, and define novel targetable genes and pathways for patients with ETP-ALL.